Longitudinal Mechanisms of Food and Nutrition Security and Cardiometabolic Health in PROSPECT

PROJECT SUMMARY
Access to sufficient, high-quality, and safe food and nutrition is a fundamental human right. Lacking this
denotes food insecurity (FI), becoming a significant societal and public health crisis. FI increases the risk of
type 2 diabetes and cardiovascular disease. Yet, there is insufficient evidence on the causal link and potential
mediating mechanisms between FI and cardiometabolic disease (CMD). Posited pathways are neuroendocrine
factors, dietary factors, such as dysfunctional eating or specific fats like trans fats or ceramides, and positive or
negative psychological factors. But few studies have investigated these pathways. It is also unclear how
persistent vs. transient FI influences CMD. Moreover, the impact of food procurement decisions on FI and diet
quality has been barely studied. These gaps are largely due to scant comprehensive longitudinal studies,
leading key agencies to call for rigorous research on the mechanisms linking FI and CMD in vulnerable groups.
Due to social and cardiovascular-related inequities, compounded by vulnerability to climate-change events,
FI prevalence in the US territory of Puerto Rico (PR) is 33.2%, three times the US prevalence. This makes PR a
pressing case and an ideal setting to study contributors to - and health consequences of - FI. With the goal of
elucidating the complex pathways connecting FI and CMD, in 2018 we established PROSPECT: Puerto Rico
Observational Study of Psychosocial, Environmental, and Chronic disease Trends (R01-HL143792), a
longitudinal cohort of adults aged 30-75 y. PROSPECT includes a thorough clinical examination and collects
blood, urine, saliva, and hair samples to assess CMD, and validated psychosocial measures, a food frequency
questionnaire, geocoded food access metrics, and the USDA Food Security Survey Module. Our reports show
that 73% of participants have abdominal obesity, 61% have high blood pressure, 33% have FI, and 53% receive
the Nutrition Assistance Program. We propose to renew PROSPECT to assess CMD at 4y and 6y post-baseline,
screen for transient FI between visits, and analyze circulating fatty acids and novel biomarkers. We will enrich
representation from rural areas and men, key CVD factors, with 500 new participants. Over 6y, we aim to
determine associations between persistent and transient FI and CMD, directly or via neuroendocrine markers;
identify dietary and psychosocial mechanisms linking FI and CMD; and identify food procurement factors
associated with FI and diet. Exploratory analysis will georeference climate change indicators with FI.
PROSPECT leverages an established interdisciplinary team, a thorough dataset, multiple timepoints to
examine complex pathways, novel biomarkers, and original analysis of FI and climate-change events. We have
already produced pivotal publications, action-oriented initiatives, ancillary studies, and a biorepository and
research infrastructure in PR. This renewal will enhance our unique cohort and generate compelling results
that will advance science by elucidating mechanisms between FI and CMD, serving as model for other groups,
and will inform food-related and psychosocial programs to alleviate FI and CMD inequities in PR and beyond.

Public health relevance
NARRATIVE Food insecurity is present in 11% of the US population, but disparately higher at 33% in the US territory of Puerto Rico that is simultaneously experiencing social and cardiovascular-related inequities, compounded by vulnerability to climate change events. The lack of systematic, longitudinal studies has hindered understanding of the complex mechanistic pathways connecting food insecurity to cardiometabolic disease, posited to operate through biological, diet-related, or psychosocial factors, nor their interconnections with food procurement or climate-change indicators. To address this, we will extend and enrich the existing rigorous and comprehensive data from the highly-productive Puerto Rico Observational Study of Psychosocial, Environmental, and Chronic disease Trends (PROSPECT), a longitudinal cohort of adults in PR, to generate compelling evidence elucidating the mechanisms between food insecurity and cardiometabolic disease, and to inform programs and policy that can alleviate these inequities in PR, while serving as a model for other populations.